PULSE - BRIDGE-C2: DeveloPing a Pragmatic GUide to ImpLementing Social RiSk AssistancE

PROJECT SUMMARY
This supplement is a collaborative effort across four ISC3 Centers: BRIDGE-C2, Harvard ISCCCE, University
of Washington OPTICC, and Washington University-ISC3. The BRIDGE-C2 Center Implementation Laboratory
is a network of community health centers (CHCs), which face particularly difficult implementation challenges as
they primarily serve socioeconomically vulnerable patients with high rates of social needs (adverse social
determinants of health). Addressing social needs through `Assistance' interventions can be critical to ensuring
patients' ability to access evidence-based cancer screening and prevention interventions. Well-documented
challenges in addressing social needs include determining how best to maintain up-to-date information about
available service agencies to which persons with social needs may be referred, and developing and adopting
optimal workflows for doing so. Methods for doing so range from having a clinic social worker maintain a hard-
copy binder of resources, to using social service resource locators (informatics platforms integrated into the
electronic health record) to identify available resources and enable bidirectional communication with local
organizations about patients' receipt of services (also called community resource referral platforms). Building
on findings from the Phase I supplement, we propose to: (1) develop a pragmatic, applied guidebook (the
Guide) for clinics seeking to implement or expand efforts to address patient-reported social risks using
Assistance strategies; (2) use rapid-cycle testing to identify best practices for implementing the Guide; and (3)
iterate and disseminate the refined Guide.

Public health relevance
PROJECT NARRATIVE This supplement is a collaborative effort across four ISC3 Centers: BRIDGE-C2, Harvard ISCCCE, University of Washington OPTICC, and Washington University-ISC3. We propose to: (1) develop a pragmatic, applied guidebook (the Guide) for clinics seeking to implement or expand efforts to address patient-reported social risks using Assistance strategies; (2) use rapid-cycle testing to identify best practices for implementing the Guide; and (3) iterate and disseminate the refined Guide. This supplement will support and enhance the research conducted by the BRIDGE-C2 Center, as social risks (adverse social determinants of health) drive health inequality and health disparities in receipt of guideline-concordant cancer prevention.